Investigating the developmental programming of hematopoietic stem and progenitor cells

Project Summary/Abstract
Hematopoietic stem and progenitor cells (HSPCs) reside in a microenvironment that regulates their behavior by
interactions with niche support cells. During development of the mammalian embryo HSPCs are born in the
dorsal aorta and migrate to the fetal liver, where they expand and differentiate. Fetal liver HSPCs are proliferative
and when transplanted have a greater capacity for reconstituting the blood system compared to quiescent adult
HSPCs. However, the genetic networks regulating fetal liver HSPCs, and their maturation, are poorly understood.
To dissect these networks, we are characterizing a viable integrin α4 (itga4) mutant zebrafish model with
perturbed interaction between HSPCs and the mammalian fetal liver equivalent—the caudal hematopoietic
tissue (CHT). Preliminary analysis of HSPCs at 5 days post fertilization (dpf), after migration from the CHT to the
presumptive adult kidney marrow niche, detected transcriptomic and epigenomic differences between wild-type
(WT) and itga4 mutant HSPCs, indicating reprogramming of HSPCs after interaction with the CHT niche. Gene
Set Enrichment Analysis (GSEA) of differentially expressed genes between WT and itga4 mutant HSPCs
showed enrichment of inflammatory signaling in itga4 mutant HSPCs which did not lodge in the CHT niche. Motif
analysis of accessible chromatin regions unique to itga4 mutant HSPCs revealed potential regulatory factors of
HSPC reprogramming, such as ets1 and AP-1 factors. We hypothesize that bypass of the CHT niche prevents
correct HSPC programming and transition to quiescence, causing itga4 mutant HSPCs to remain in an immature
state. In Aim 1, we will analyze the proliferative capacity, inflammatory profile, and stem cell capacity of HSPCs
that did (WT) or did not lodge in the CHT niche (itga4 mutant) to characterize the programming event initiated
by itga4-mediated interactions between HSPCs and the CHT niche. In Aim 2, we will map the epigenomic
landscape and perform multiomic analysis of WT and itga4 mutant HSPCs to determine the gene regulatory
networks underlying the developmental switch of HSPCs from proliferation to quiescence. We will utilize our
unique zebrafish system and multiomic approaches to dissect the developmental networks of HSPC regulation.
By understanding the transitions between proliferative and quiescent HSPC states, our findings could translate
into novel approaches for stem cell expansion and improved stem cell therapy.

Public health relevance
Project Narrative Hematopoietic stem and progenitor cells (HSPCs) are regulated by their microenvironment, however the reprogramming signals they receive from the niche during development are not well understood. My research will use an integrin alpha 4 mutant zebrafish model that prevents HSPC-niche interactions during development, allowing dissection of the gene regulatory networks that control the transition of HSPCs to quiescence. Our findings will link cell extrinsic signals to intrinsic changes in HSPCs that regulate the switch between proliferation and quiescence, potentially transforming our approaches for in vitro stem cell expansion and treatment of hematologic malignancies.